A Theory-Driven Modification of a Motivational Interviewing Intervention Targeting Alcohol Misuse Among Hispanic Americans

:
Hispanic Americans with various identities have been identified as under-resourced communities that may be at increased risk for binge drinking behavior and alcohol-related problems. These issues have been linked to various social stressors and may be mitigated through accessing resilience and various sources of strengths. There is one promising intervention, CAMI that has shown efficacy in decreasing alcohol misuse within Hispanic Americans. Specifically, CAMI is a tailored intervention for Hispanic Americans individuals that targets stress related to adapting to a new host culture and has shown strong promise in its reduction of alcohol misuse. However, CAMI only address singular forms of social stressors and does not account for various sources of support, strengths, and resilience. Therefore, CAMI will be adapted using an evidenced based, theory driven model of adaptation of behavioral therapies to address various forms of social stressors that Hispanic Americans encounter, in efforts to decrease high rates of alcohol misuse. The new intervention will be delivered via telehealth, it will be available in English and in Spanish, with traditional motivational interviewing used as the controlled condition. The study will be conducted in New England (NE) and in the Southwest (SW) to account for geographical differences among Hispanic Americans. The study will be conducted in three phases: in-depth qualitative interviews with Hispanic Americans (n=20) and clinic stakeholders from NE and the SW (n=10; aim 1) to capture strengths and social stressors and links to alcohol misuse and receive feedback on the adaptation of the manual; the second phase will be open series where it will focus on examining feasibility and acceptability of the novel intervention and it will be tested with 16 Hispanic Americans (n= 8 from NE; n= 8 from SW) and feedback will be incorporated into the treatment protocol (aim 2); the third phase will be a pilot randomized controlled trial (RCT) with 60 Hispanic Americans with 30 participants from NE and 30 participants from the SW (15 receiving the new intervention and 15 receiving MI from each region; aim 3). The goals of the current study are consistent with NIAAA’s identified special populations and strategic plan. The current K23 will facilitate the applicant’s development of expertise in randomized-controlled trials, addiction science, and community-engaged research.

Public health relevance
The current study aims to improve and adapt a prior motivational interviewing intervention tailored for Hispanic Americans to address alcohol misuse (i.e., CAMI). The current study aims to improve CAMI by targeting various forms of social stressor that Hispanic Americans experience by utilizing a theory-driven and evidenced model of adaptation of behavioral therapies driven by six principles (e.g., coping with social stressors, resilience, and identifying sources of strengths). The intervention will be informed by community partnerships with the aim of conducting a pilot randomized controlled trial of the novel intervention to demonstrate efficacy, acceptability, and feasibility.